Gastrointestinal Cues Influence Metabolic Control of Regulatory T cell Function

PROJECT ABSTRACT
Human inflammatory bowel disease (IBD) is characterized by inconsistent response to therapies and persistent
activation of pathogenic effector CD4+ T cells implying regulatory T cell (Treg) dysfunction; however, the
underlying mechanisms are poorly understood. Therefore, the OVERALL OBJECTIVE of this proposal is to
elucidate the mechanisms by which gastrointestinal cues impact Treg metabolism and function with the
therapeutic goal of defining pharmacological and adoptive Treg therapies to treat IBD. For the first time using
complementary approaches, we have observed a defined mitochondrial ultrastructure (shape, cristae structure,
and physical interaction with the endoplasmic reticulum [ER]) which correlated with Treg metabolic state. We
are now poised to exploit how: i) mitochondrial ultrastructure and its associated metabolic state in Tregs
suppress gut inflammation in various mouse models of experimental colitis; and ii) a breakdown in the
regulation and function of mitochondrial ultrastructure can drive human IBD pathogenesis by analyzing Tregs
from peripheral blood and lamina propria of IBD patients compared to relevant healthy individuals. Our
preliminary data suggest that anti-inflammatory transforming growth factor beta 1 (TGF-β1) cytokine is a critical
driver of mitochondria-ER contact (MERC) in Tregs via its associated molecular architecture, thus implicating
intact MERC and subsequent pyruvate oxidation in Treg-mediated suppression of IBD. In our preliminary
experimentations mimicking the proinflammatory milieu of IBD gastrointestinal tract, treatment of Tregs with
proinflammatory cytokines impaired MERC and perturbed glucose metabolism, leading to excessive fatty acid
oxidation as a compensatory mechanism in contrast to vehicle-treated Tregs (“proinflammatory cytokine-
induced metabolic reprogramming”). Furthermore, we discovered that proinflammatory cytokine-induced
metabolic reprogramming of Tregs was reversed by inhibiting the activity of glycogen synthase 3 beta (GSK3β)
using a class of inhibitors currently being explored in clinical trials for other indications. Based on these novel
observations, we formulated the CENTRAL HYPOTHESIS that TGF-β1 mediates mitochondria-ER contact
that is essential for cellular metabolic homeostasis, Treg function, and suppression of IBD pathogenesis. The
following independent SPECIFIC AIMS are designed to test three integrated hypotheses. First, we will directly
test the hypothesis that TGF-β1 mediates MERC and consequently Treg function. Second, we will test the
hypothesis that TGF-β1 potentiates mitochondrial pyruvate oxidation and consequently Treg function. Third,
we will test the hypothesis that proinflammatory cytokines perpetuate IBD pathogenesis in vivo via MERC
inhibition. We propose to utilize sophisticated approaches relevant to health and IBD pathophysiology to test
this hypothesis. This proposal, which is technically and conceptually innovative, is also significant because it
presents a novel concept in Treg biology and identifies new mechanisms for therapeutically optimizing Tregs,
namely combining pharmacological and Treg-based therapies, to halt the refractory nature of IBD.

Public health relevance
PROJECT NARRATIVE The proposal examines how a particular type of immune cell responds to its environment during the development of human inflammatory bowel disease by using animal models and different forms of this immune cell to treat this disease in animals. The goal of our research is to understand how this immune cell, termed “regulatory T cells,” in the intestine can be optimized to better suppress the disease. Information gained from this study will help identify approaches to inhibit excessive inflammation and provide treatment strategies for stopping this debilitating condition that destroys bowel.